POSTDOCTORAL TRAINING IN THE STUDY OF AGING

DESCRIPTION (provided by applicant): RAND offers a rich, unique environment for advanced training in the study of aging. It is one characterized by a strong emphasis on interdisciplinary research, supported by nine Centers dedicated to the study of myriad aging issues, a diverse and distinguished group of scholars, excellent facilities and strong research support services, and the availability of formal instruction in various research skills. We propose five more years of support for two postdoctoral fellows per year, beginning in 2010.